RCT to improve multisensory neural processing, language & motor outcomes in preterm infants

PROJECT SUMMARY/ABSTRACT
Every year, ½ million infants are born prematurely in the US and 15 million worldwide. Almost all preterm
infants suffer from abnormal brain maturation resulting from interactions between brain immaturity and an
atypical early extra uterine experience. At discharge to home they often have altered reactivity to sensory
experiences in the home, associated with worse developmental outcomes in childhood. To improve these
outcomes, it is critical to intervene in neonatal period when plasticity and cascading effects have the greatest
potential. The need exists to design rigorous, standardized and mechanistically-based multisensory
interventions leveraging parent support, in order to improve measurable multisensory neural processing in the
neonatal period, with downstream effects on sensory reactivity in the home and better language and motor
outcomes in early childhood. The overarching goals of this proposal are therefore to validate a safe, dyad-
centered therapy constructed with easily available technology and parent-derived stimuli, adaptable to a wide
variety of neonatal environments.
To accomplish this, we propose a randomized controlled trial with intent-to-treat analysis in 200 hospitalized
preterm infants between 32 and 36 weeks' post-menstrual age. The multisensory intervention, which includes
12 sessions of standardized, therapist-administered, auditory-tactile stimulation, and combines contingent
recorded mother's voice delivered using a pacifier-activated system during holding with supportive tactile
containment against the therapist's chest. Our approach incorporates an easy-to-use FDA approved pacifier-
activated device to play parents' voice in response to infant suck on a pacifier. The containment hold
approximates a care approach shown to improve muscle function, infant neuroregulation, parent-infant
bonding, and deep sleep. The intervention group will receive the treatment in addition to monitored standard
care. The contrast group will receive only monitored standard of care (i.e., skin-to-skin care by parent and daily
sessions of parent's voice recording exposure). Multi- and uni- sensory neural processing will be measured at
entry into the study and after the treatment phase, using novel event-related potential (ERP) assessments, as
they are rapid and non-invasive, requiring neither active participation nor directed attention. Sensory reactivity
will be measured at 1 year. Language and motor outcomes will be tested at 2 years.
The short-term objective of this proposal is to directly test the hypothesis that multisensory treatment affects
neuro-developmental outcomes through its effect on multisensory processing. We will also obtain quantitative
and mechanistically relevant information on group response to treatment to help optimize future intervention
designs and implement them in multiple neonatal care settings where parents cannot continuously be present
at their child's bedside.

Public health relevance
PROJECT NARRATIVE Every year, almost ½ million infants born prematurely in the US and 15 million worldwide suffer from abnormal brain maturation resulting from interactions between immaturity and atypical sensory experiences after birth. The current proposal uses rigorous scientific methods to measure the effects and determine the mechanisms of action of a parent-supported multisensory neurorehabilitative intervention for preterm infants, adaptable to a wide variety of neonatal environments, even when parents cannot be at their child’s bedside. The intervention aims to improve brain multisensory processing, reactions to sensory stimulation in the home and long-term language and motor development.